FoxO transcription factors in joint aging and osteoarthritis pathogenesis

ABSTRACT
Osteoarthritis (OA) is the most prevalent joint disease. Although aging represents one of the most important
risk factors for OA, mechanisms leading to the aging-related cartilage degeneration remain to be determined.
We reported that cellular homeostasis mechanisms such as autophagy and oxidant defenses are
compromised in aging and OA-affected cartilage. In our recent studies we investigated FoxO transcription
factors, which regulate expression of autophagy proteins and autophagy activation. FoxO3a in particular is
known as molecular gatekeeper of cellular aging. We observed a reduction in FoxO mRNA and protein
expression in aging and OA-affected cartilage in humans and mice.
These findings support the hypothesis that ‘Aging-related reduction of FoxO expression impairs protective
cellular homeostasis mechanisms, compromises chondrocyte survival and biosynthetic capacity and leads to
accelerated joint aging and initiation of OA pathogenesis’. This hypothesis will be tested in the following aims.
Aim 1: Regulation of FoxO expression and function in chondrocytes. We will examine the extracellular
regulators and mechanisms of FoxO suppression or activation and identify the responsible cis-elements in the
FoxO promoters. Using in vitro models of FoxO knock down and overexpression in normal and OA human
chondrocytes and cartilage explants from FoxO deficient mice we will examine the role of FoxO in regulating
chondrocyte functions.
Aim 2: The FoxO signaling network in cartilage. FoxO target genes are tissue and context specific. We will
establish FoxO target genes in mouse cartilage and human chondrocytes by using RNA-seq, ChIP-seq and
ChIP-seq for histone marks. Integrative analysis of these datasets will identify pathways and signaling
mechanisms that are regulated by FoxO.
Aim 3: Role of FoxO in cartilage homeostasis, aging and experimental OA. Our preliminary studies show
that conditional cartilage specific deletion of FoxO1 leads to abnormal cartilage growth postnatally and
spontaneous OA-like degradation by 6 months. We will generate postnatal triple and single knock out mice
using Acan-CreER and test them for aging related changes and severity of experimental OA.
Aim 4: Protective effects of FoxO overexpression and activation
We will generate mice that overexpress active forms of FoxO1 or FoxO3 in cartilage to balance the OA
associated suppression and determine outcomes with respect to homeostasis mechanisms and OA severity in
the aging and surgical models.
This project will establish that aging-related reduction in FoxO expression is an early and critical event in OA
pathogenesis. This will provide the foundation for therapeutic approaches aimed at modulating FoxO
expression and/or activity to prevent age-related and injury-induced onset and progression of OA.
!

Public health relevance
PROJECT NARRATIVE This study is based on our recent findings that the expression of FoxO transcription factors is suppressed in articular cartilage from aged and osteoarthritis-affected human and mouse joints. The proposed research will investigate the role of FoxO in joint homeostasis, consequences of FoxO suppression in joint aging and osteoarthritis pathogenesis and determine potential therapeutic benefits of increasing FoxO expression. The findings from this work have potential to lead to a paradigm shift in the understanding of the impact of joint aging on osteoarthritis pathogenesis and lead to new approaches to prevention and treatment. !